Suicidality in autistic adults: The role of social adversity, trauma, and protective factors

ABSTRACT
This project directly addresses autistic community priorities on adult mental health and the Interagency Autism
Coordinating Committee’s call for research to reduce premature mortality (i.e. suicide). Autistic adults are at
heightened risk for suicidal ideation (SI) and suicidal behaviors (SB). As many as 50% of autistic adults report
experiencing SI and over 40% report SB in the past 12 months, with the peak incidence of risk occurring in early
adulthood. Yet, little else is known about which autistic adults are at the most risk or which risk and protective
factors may moderate this heightened risk. Autistic adults experience disproportionate exposure to traumatic
events and social adversity (hereafter collectively referred to as “adversity”) due to their marginalized social
status. Adversity is associated with SI and SB in other populations but has yet to be tested in autism. Further,
negative neurocognitive processes common in autism likely increase vulnerability for SI/SB following adversity,
and it is unclear if established protective factors of suicide in non-autistic adults are similarly protective in autism.
Taken together, we lack understanding of factors that increase and reduce the risk for suicide in this population.
Using a community engaged-approach, we comprehensively test the relationship between adversity and
suicidality in autistic adults. We will enroll a sample of 250 autistic adults (age 18-40) into a longitudinal study
that tests the relationship between adversity and SI/SB. At least half of our sample will be at high-risk for suicide
(i.e. active SI or SB in the past 6 months). Our design focuses on multiple temporal scales with a comprehensive
longitudinal assessment battery (i.e. baseline, 6-months, 12-monts) and collection of brief daily diaries for 8-
consecutive weeks at baseline. We will identify the most salient proximal (i.e. daily) and longitudinal indicators
of adversity (i.e. traumatic events, discrimination, invalidation, victimization, stigma social rejection) that predict
SI and SB. Further, our project will identify risk and protective factors that moderate the relationship between
adversity and suicidality. Specifically, Aim 1 will establish the longitudinal relationship between adversity and
SI/SB in autistic adults. In Aim 2, we will determine how daily adverse experiences relate to proximal risk for SI
in autistic adults. We will integrate these findings in Aim 3 to create latent class groups of suicide risk trajectories,
which we will characterize to identify groups of autistic adults that are most at risk for suicide. Our premier
environment at the University of Pittsburgh will ensure that our project successfully engages autistic adults from
groups that have been marginalized, ultimately enriching our sample, outcomes, and overall impact. Findings
will identify which factors contribute to the most risk of suicide, which will ultimately advance our identification of
mechanistic targets for suicide intervention development and testing. We will rapidly disseminate this information
to the autistic and healthcare communities with our established network of partners to speed the translation of
this important work.

Public health relevance
PROJECT NARRATIVE This project will fill a void in research on autistic adults and their heightened risk for suicide. Using a community-engaged approach, we will test the impact of chronic exposure to traumatic events and social adversity in relation to suicide risk among autistic adults. We will generate new mechanistic targets for future suicide prevention and intervention efforts that aim to reduce premature mortality for autistic adults.